An integrative omics approach to investigate gene-environment interaction in colorectal cancer risk

PROJECT SUMMARY/ABSTRACT
Colorectal cancer (CRC) remains one of the leading causes of cancer-related deaths around the world.
Many environmental risk factors and over 200 genetic risk variants have been identified for this complex,
multifactorial disease. However, despite the strong biological rationale for the importance and abundance of
gene-environment (GxE) interactions, the extent to which environmental risk factors (broadly defined here as
lifestyle, diet, obesity, drug use and intermediate biomarkers) modulate genetic risk factors is poorly understood.
To achieve the promise of precision prevention, we urgently need to gain a deeper understanding of GxE
interactions in CRC risk. Understanding which modifiable risk factors modulate genetic risk, which is fixed,
provides biological insights and actionable targets for new prevention intervention strategies. To accelerate the
discovery of GxE interactions in CRC risk and to take an important next step towards translation, we propose a
comprehensive innovative approach that combines single-cell multi-omics data, individual-level harmonized
epidemiological and clinical data, and genome-wide data from large, well-characterized, diverse study
populations, with novel computational and statistical approaches. Dramatic improvements in single-cell
multimodal omics technologies, combined with new computational tools based on powerful deep-learning
modeling approaches now allow us to predict the impact of genetic variants on gene regulation in a cell-type-
specific holistic manner. Because simultaneously measured single-cell gene expression (scRNA-seq) and
chromatin accessibility (scATAC-seq) data for normal colorectal mucosa tissue is lacking for racially and ethnically
diverse samples with detailed assessment of environmental risk factors, we propose in Aim 1 to generate such
data for 50 individuals. This resource, together with other single cell multi-omics compendia for colorectal tissue
(like HTAN), will be leveraged to develop functional prediction scores for genetic variants across the genome. In
Aim 2, we will use these functional prediction scores to boost statistical power for discovery of novel GxE
interactions. We will perform genome-wide GxE scans in over 230,000 racially and ethnically diverse CRC cases
and controls across key environmental risk factors, including obesity, diabetes, smoking, alcohol, drug use,
dietary factors and intermediate biomarkers linked to metabolic dysregulation and chronic inflammation. To
expand the number of key risk factors we can evaluate, we will utilize existing genetic instruments. In Aim 3, we
will comprehensively characterize and translate GxE interactions. To do so, we will stratify GxE findings by
clinical factors, including age of onset, racial and ethnic group, sex, and tumor subtypes. Additionally, we will
incorporate GxE interactions and genetically predicted biomarkers in a comprehensive trans-ancestral risk
prediction model to improve prediction and provide actionable information to reduce the burden of CRC. Our
community advisors have stressed the importance of including the interplay between genetic and environmental
risk factors in risk prediction modeling to enhance the acceptance of risk prediction models in the community.

Public health relevance
PROJECT NARRATIVE This multidisciplinary effort aims to accelerate the discovery of gene-environment (GxE) interactions that influence colorectal cancer (CRC) risk. We will conduct functional-genomic guided genome-wide GxE scans in over 230,000 racially and ethnically diverse CRC cases and controls across the spectrum of environmental risk factors. This approach improves the statistical power and biological interpretability of GxE findings. Discoveries have high translational potential for precision prevention as they can guide lifestyle interventions as well as personalize screening decisions, ultimately, reducing the burden of CRC.